ISCHEMIC HEART DISEASE IN INDICES OF BODY FAT DISTRIBUTION

This study is complete and did not admit patients during this reporting period. It utilized the biostatisticians for graphical analysis. Citations are included in the Publications section.